Investigation into nTS mu opioid receptor mechanisms contributing to fentanyl-induced cardiorespiratory depression

PROJECT SUMMARY
This project aims to explore mechanisms involving mu opioid receptor (MOR) signaling within the nucleus of the
solitary tract (nTS) in mediating fentanyl-induced cardiorespiratory depression. Over the past decade, synthetic
opioids, primarily fentanyl, have been the leading cause of the surge in opioid-related deaths. Fentanyl presents
a significant treatment challenge due to its rapid onset of effects, which makes timely intervention strategies
difficult to implement. Numerous studies have examined opioid-MOR mechanisms in ventral brainstem
respiratory networks as key factors in the development of opioid-induced respiratory depression (OIRD). The
nTS, located in the dorsal brainstem, contains robust mu opioid receptor expression, including vagal afferent
fibers that terminate in this region as well as postsynaptic expression on nTS neurons themselves. Despite this
abundance of MOR in the nTS, the extent to which the nTS mediates OIRD has not been thoroughly investigated.
Therefore, the goal of this proposal is to examine mechanisms by which opioids impact neuronal activity within
the nTS, and how this relates to the onset, severity, and duration of OIRD. We will employ various complementary
techniques to evaluate opioid-MOR mechanisms within the nTS. Aim 1 will utilize a newly generated transgenic
MOR-Cre rat line, combined with chemogenetics, optogenetics, and fiber photometry, to evaluate presynaptic
and postsynaptic mechanisms of fentanyl-MOR signaling in the nTS. Aim 2 will use two additional transgenic rat
lines to evaluate how vagal afferent fibers mediate the activity of catecholaminergic and GABAergic nTS neurons,
and how fentanyl impacts this vagal signaling to these nTS neuronal subpopulations. This aim will employ fiber
photometry, chemogenetics and immunohistochemistry to examine these peripheral-central circuits in the
context of OIRD. Aim 3 will utilize transgenic rat lines to determine how opioids directly impact the activity of
catecholaminergic and GABAergic nTS neurons whether they are necessary for the onset, severity, or duration
of OIRD. Additionally, this aim will utilize a transgenic mouse line in which MOR has been knocked out of
noradrenergic cells. Experiments using these mice will determine the extent to which MOR-expressing
noradrenergic cell groups, including in the nTS, contribute to the induction and severity of OIRD. This research
will be supported by primary mentor Dr. Jose Moron-Concepcion at Washington University in St. Louis and co-
mentor Dr. Jordan McCall at Washington University in St. Louis and the University of Health Sciences &
Pharmacy in St. Louis. Additional external support will come from Dr. Erica Levitt at the University of Michigan
and Dr. Kevin Cummings at the University of Missouri. By investigating opioid mechanisms in the nTS, the
overarching goal of this research is to advance our understanding of how opioids induce cardiorespiratory
depression, potentially by preventing the engagement of reflex responses that would normally be engaged to
facilitate a return to cardiorespiratory homeostasis. Data generated during this project period seeks to contribute
to the development of new therapeutic strategies for managing OIRD in individuals with opioid use disorders.

Public health relevance
PROJECT NARRATIVE The recent surge in opioid overdose deaths is primarily due to the rise and distribution of the synthetic opioid fentanyl, known for its high potency and rapid onset of respiratory depression. This proposal aims to evaluate mechanisms underlying fentanyl-induced dysfunction in the nucleus of the solitary tract (nTS), a dorsal brainstem nucleus that mediates cardiorespiratory function. The results of this work seek to establish the role of mu opioid receptors in the nTS in determining the severity and duration of respiratory depression following intravenous fentanyl exposure.